Multidimensional phenotype classification in grade 3 BPD

PROJECT SUMMARY/ABSTRACT
Bronchopulmonary dysplasia (BPD) is a severe chronic lung disease that develops over the first months of
life in more than half of infants born less than 30wk of gestation. Infants who develop grade 3 BPD, the most
severe disease form (defined as invasive ventilation at 36wk postmenstrual age), are at high risk for life-long
deficits in health and cognition and poor quality of life. Unfortunately, rates of grade 3 BPD are increasing, and
no therapies have been proven to treat this devastating disease. A key contributor to these care gaps is the
nearly singular reliance on the prescribed respiratory support to define BPD presence and severity, select
therapeutic interventions, and assess prognosis. Our data and others’ show that this subjective diagnostic
approach masks significant heterogeneity in clinical presentation, treatment responsiveness, and outcomes. In
other heterogenous chronic respiratory conditions such as COPD, cystic fibrosis, and asthma, evidence-
based phenotyping (identification of patient subgroups based on shared characteristics) has become the new
gold-standard to objectively classify distinct disease sub-types, improve patient counseling, identify novel
disease mechanisms, and discover and implement more effective treatments. Our central hypothesis is that
multidimensional phenotyping in grade 3 BPD is feasible, will accurately characterize disease heterogeneity,
and will improve outcome prediction. Confirmation of this hypothesis will promote a frameshift towards an
objective, systematic diagnostic approach in BPD and first-ever phenotype-specific trials in neonatology.
Importantly, our motivating preliminary data support this hypothesis. Using retrospective results from
chest CT, cardiac echo, and bronchoscopy, we showed that preterm infants with grade 3 BPD can be
classified into phenotypes based on the presence or absence of severe parenchymal lung disease, abnormal
large airways, and pulmonary arterial hypertension. This diagnostic approach correlated with pre-discharge
outcomes and suggested possible phenotype-specific therapies. However, it relied on investigator chosen
phenotypes rather than empirically derived subgroups, used qualitative results from only 3 diagnostic tests,
and did not assess longitudinal phenotype stability or post-discharge outcomes. Our recent data indicate that
serial quantitative cardiopulmonary imaging and evaluation of proven mechanistic contributors to BPD may
improve disease phenotyping and outcome prediction. Our proposal builds on these preliminary data and will
employ robust cluster analyses and longitudinal multidimensional imaging, biological, and clinical data in a
large, prospective cohort of very preterm infants to accomplish the following Specific Aims: (1) define
objective, evidence-based phenotypes in grade 3 BPD, and (2) define the strength of association between
grade 3 BPD phenotypes and neurodevelopmental and pulmonary outcomes through 2 years’ corrected age
using standardized development testing and validated outcome measures.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia (BPD), or chronic lung disease of prematurity, is the most consequential complication of preterm birth and is strong predictor of childhood pulmonary and neurodevelopmental disability, particularly in infants diagnosed with grade 3 BPD (ventilator dependence at 36 weeks’ postmenstrual age), the most severe disease form. In this proposal, we outline our plan to (1) generate the first empirically defined phenotype classification system for grade 3 BPD developed using a rich array of objective and quantitative cardiopulmonary diagnostic, clinical, and biological data; and (2) define the association between phenotype subgroups and neurodevelopmental and respiratory outcomes through 2 years’ corrected age. Successful completion of this research will promote a long-overdue frameshift in neonatal medicine towards objective disease classification in BPD using evidence-based diagnostic testing and performance of first-of-their-kind phenotype-specific trials targeting more effective individualized care.